Development and Application of New Ionization Methods for Biological Mass Spectrometry

PROJECT SUMMARY
Mass spectrometry is an extraordinarily powerful bioanalytical technique that has
had a profound impact on our molecular understanding of human health and
disease. Major advances in mass analyzer technology, dissociation techniques,
lasers, and ionization methods are largely attributed to the central role that mass
spectrometry plays in the field of systems biology. While mass spectrometry has
evolved over the last century into a highly effective analytical tool, there remain
significant opportunities for innovation, allowing an even more diverse array of
biological questions to be addressed. This proposal is centered on the
development of new ionization methods for biological mass spectrometry to
enable tissue imaging across several classes of biological molecules. The short-
term objective of this proposal is to further develop and fundamentally
understand this innovative ionization method using real biological systems.
These results will provide a solid foundation from which biological applications
will directly benefit. In this mindset, we will develop and apply these new
ionization methods to tissue imaging in model organisms to gain mechanistic
insights into, 1) ischemic stroke; 2) wound healing; and 3) cardiometabolic
disease. The long-term objective is to establish these new ionization methods as
an enabling bioanalytical technology to effectively address questions in human
health and disease.
Public Description of Proposed Research
Mass spectrometry (MS), the science related to the “weighing of molecules”, has
had a profound impact on the study of human health and disease including
cancer, heart disease, neurodegenerative diseases, neural development, and
auto-immune diseases. A prerequisite of MS is to convert neutral molecules into
charged species (ions) such that they can be “weighed” by the mass
spectrometer and identified by advanced analytical techniques. The focus of this
research is to develop new ionization methods allowing a more diverse array of
contemporary biomedical questions to be addressed. This will include the
imaging of tissues to ultimately provide new biological insights into stroke, wound
healing and cardiometabolic disease.

Public health relevance
PROJECT NARRATIVE This proposal seeks support to develop a NextGen novel ionization method and variants thereof for biological mass spectrometry that will transform tissue imaging (molecular microscopy). Furthermore, the tissue imaging data will be derived from serial tissue sections and ablation based 3D imaging with multiple lines of biological readouts (e.g., neurotransmitters, lipids, glycans) providing new insights into important human health and disease (stroke, wound healing, cardiometabolic disease). In summary, we will establish a disruptive enabling bioanalytical technology through detailed characterization using real biological systems; this new technology and the underlying processes, hardware and software components will be fully documented and freely shared with the imaging community, and many of the proposed advances can readily be adapted by other MSI platform technologies to transform the entire MSI field since the MSiReader software is agnostic with respect to mass spectrometry platform, laser wavelength, biological system, or disease and is driven by the needs of the entire MSI community.